Supporting and evolving Gene Set Enrichment Analysis and the Molecular Signatures Database for cancer research

Project Abstract

Gene Set Enrichment Analysis (GSEA) introduced in 2003, is now standard practice for analyzing genome-­
wide expression data. GSEA derives its power from identifying the activation/repression of sets of genes that
share common biological function, chromosomal location or regulation and differentiate biological phenotypes
or cellular states. This knowledge-­based approach is effective in elucidating underlying biological mechanisms
and generating hypotheses for further study and experimental validation. Since 2005, we have developed,
distributed and supported a freely available GSEA software application along with a database of annotated
gene sets – the Molecular Signatures Database (MSigDB). This popular resource has more than 113,000
registered users and over 10,200 citations in the literature, and the MSigDB has almost 18,000 annotated sets.
The goal of this proposal is to continue to evolve and add value to the GSEA/MSigDB resource to best address
the needs of the cancer research community, while maintaining the high level of professional quality and strong
support that investigators have come to expect. We plan to increase the power and sensitivity of the GSEA
method and enrich the MSigDB to further accelerate the pace of genomic research. Our specific aims are:
Aim 1: Develop and deploy the next generation of the GSEA method and software to keep pace with
the needs of the cancer research community. The new core algorithm will be based on information-­
theoretic approaches, guided by a collection of 100 relevant benchmarks and informed by an Advisory
Board of established cancer researchers. To facilitate the use of GSEA by researchers at all levels of
computational sophistication, we will distribute the GSEA analysis tools as both an open source code
library and a suite of user friendly, reproducible, interactive, electronic notebooks.
Aim 2: Extend the scope and specificity of the MSigDB, and evolve the underlying technology. In
collaboration with the community, we will add valuable new collections to MSigDB including signatures of
drug responses and genetic perturbations, sets for use with mouse models of cancer and PDXs, sets from
pathway and network databases, and sets for use with proteomic data analysis. The MSigDB will be
redesigned from its current XML file format and deployed as a lightweight, portable relational database that
can better support its growing size, online exploration tools, and use by investigators and other software.
Aim 3: Provide training and outreach activities for the cancer research community, and maintain
and support the GSEA software and MSigDB.
The success and popularity of the GSEA/MSigDB resource over the past decade;; our extensive experience in
developing computational methods for genomics research and delivering them as user-­friendly, high quality
software;; our significant user base and many citations;; our large repository of gene sets;; and our successful
delivery of documentation and training for users make us well poised to carry out the aims of this proposal.

Public health relevance
Project Narrative Gene set- based enrichment analysis is now standard practice for interpreting genome- wide expression data and elucidating the biological mechanisms associated with disease or other cellular states. The combination of the Gene Set Enrichment Analysis software and Molecular Signatures Database of gene sets representing biological processes, pathways, phenotypes, and cellular perturbations make these sophisticated knowledge- based analyses accessible to any biomedical researcher. The work in this project will significantly increase the power and value of both the analysis software and the gene set collection to better derive hypotheses for further investigation and validation and thereby accelerate and facilitate the study of important questions in biomedical and cancer research.